Gene Regulation in Innate Immunity

PROJECT SUMMARY (See instructions):
The goal of this project is to understand mechanisms of gene regulation in the innate immune response.
During the past many years, with support from this grant, we have pioneered work with fundamental
implications to our understanding of inflammatory responses. During the past 5 years, the funding stability
provided by this MERIT award, enabled us to significantly expand our field of expertise, which resulted in
several highly significant and unexpected discoveries, which form the basis of the work proposed over the
next 5 years of the award. In particular, we documented a totally novel nucleic acid binding protein CNBP
which directs Th1 immune response in vivo and connected lncRNA biology to innate immunity and the
inflammatory process. In the proposed extension of this MERIT award we will advance on the foundational
observations that linked Cnbp as a specific regulator of IL12p40 gene transcription by defining in detail the
molecular mechanisms of Cnbp-dependent control of c-Rel. We will also explore the cell type specific role
of Cnbp in controlling Th1 immunity using the T. gondii model. Further, we will explore the contribution of
Cnbp in control of the IL23-TH17 response. Lastly, we will expand on our studies of lincRNA-Cox2 to
explore regulation of Cox2 and immune responses in vivo.

Public health relevance
RELEVANCE (See instructions): The studies proposed will be highly significant in several fundamental ways: (a) they will address the specificity of CNBP for IL12 family expression; (b) they will advance understanding of how CNBP exerts cell type specific control on TH1 and TH17 immunity; (c) they will provide increased understanding of how long-non-coding RNAs impact immune gene expression and the inflammatory response in cells and animals.